A New Database to Measure the Association Between Income, Race, and Mortality: Inequality in Longevity During and Beyond the COVID-19 Pandemic

OTHER PROJECT INFORMATION – Project Summary/Abstract
A New Database to Measure the Association Between Income, Race, and Mortality: Inequality in
Longevity During and Beyond the COVID-19 Pandemic
Disparities in health and life expectancy by income are a central challenge for the United States. The highest-
income American men live nearly 15 years longer on average than the lowest-income American men; the
corresponding gap for women is 10 years. The COVID-19 pandemic has amplified these disparities by income,
race, and other dimensions. Unfortunately, we currently lack information on how mortality rates due to COVID-
19 vary with individual income, because available U.S. population mortality data lacks information on income.
The absence of this information has hindered our ability to monitor the impacts of COVID-19 and develop policies
to mitigate its impacts, particularly on disadvantaged and underserved populations, going forward. This project
will resolve these challenges by constructing a new public database of mortality rates incorporating
socioeconomic and demographic variables and covering the entire U.S. population. Using these data,
researchers will be able to analyze the sources of disparate impacts of COVID-19 on mortality across subgroups,
with the aim of understanding how to reduce health inequality in the pandemic and beyond. The project has
three specific aims. Aim 1 of this project is to release a new public database of mortality rates by age, income,
race/ethnicity, gender and county, and provide recurring annual updates to this database. This database will be
constructed by linking from tax returns, the decennial Census, and Social Security death records. Aim 2 will
characterize the short-term effects of the COVID-19 pandemic on mortality rates by race and income in 2020-
21. This analysis will measure the quantity of excess deaths and disparities in their distribution caused by the
pandemic, and identify economic and health mechanisms generating those disparities. Aim 3 will measure the
long-term effects of post-pandemic changes in health, health behaviors, labor income, tax and transfer policies,
and behaviors on racial and socioeconomic inequality in mortality. This broader set of analyses will use the
substantial disruptions generated by the pandemic to examine how and why disparities are growing or shrinking
over time. Taken together, this project will contribute to research and policy work by providing critical new data
on the relationship between socioeconomic status and health, thereby providing a tool to monitor progress in
mitigating the impacts of the COVID-19 pandemic in underserved communities.

Public health relevance
OTHER PROJECT INFORMATION – Project Narrative This project will produce an annual database of mortality rates covering the U.S. population incorporating income, race and ethnicity, and use this database to understand determinants of mortality and health inequality in the COVID-19 pandemic and beyond.